The Musculoskeletal Knowledge Portal

Project Summary
Most experiments to gain biological insights into musculoskeletal diseases or propose therapeutic targets do not
harness critical information from human genetic data. In principle, researchers can use several existing genomic
data repositories to incorporate genomic data into their research, but (a) for a researcher focused on
musculoskeletal diseases and traits, many or most vital datasets are absent from existing repositories (which
seek to be trait-agnostic); and (b) identifying, integrating, and analyzing the datasets needed for most genetic
analyses requires extensive manual labor and expertise. To address these gaps, we have developed an early-
stage resource, the Musculoskeletal Knowledge Portal (MSKKP), to enable broader sharing of genetic and
genomic data for musculoskeletal diseases and traits. In this project, we propose to transform the MSKKP into
an established biomedical knowledgebase satisfying the criteria of PAR-23-236, with the mission to integrate
`omics datasets curated by experts in musculoskeletal research, process them through analytical pipelines
developed by experts in genetics and genomics, and present the resulting knowledge through simple and easy
to access web-based visualizations. We will focus on two gaps in the current early-stage MSKKP. First, to
incorporate the numerous genomic datasets accrued by the international network of musculoskeletal researchers
over the past decade, we will aggregate and integrate newly available `omics datasets in bone, cartilage, tendon,
synovial fluid, and muscle, as well as data from unique model organism knockouts deeply phenotyped for
musculoskeletal traits. Second, to better define the functionality and incorporated datasets of the MSKKP, and
to ensure that it is accessible to a broad array of users, we will establish a transparent governance structure and
build a trusted and sustainable infrastructure for it. The proposed knowledgebase has scientific significance,
responding to an urgent need by the National Institute of Arthritis and Musculoskeletal and Skin Diseases to
create a knowledgebase for musculoskeletal diseases that aggregates and integrates genomic datasets of many
types in one accessible location. It will engage the musculoskeletal community in all aspects of the development
cycle, ranging from data identification to quality control to knowledgebase functionality, and will conform to FAIR
principles. Finally, it will be governed by researchers with diverse areas of expertise who collectively will ensure
its trustworthiness. The impact of the proposed project will be an established knowledgebase providing basic
and clinical scientists ready access to musculoskeletal genetic and genomic data, as well as the tools needed to
integrate and apply these data to their own research questions. Growing the MSKKP into an established resource
is a critical need for the musculoskeletal community and will help unlock the potential of human genetics to
advance the understanding and treatment of musculoskeletal conditions.

Public health relevance
Project Narrative The primary goal of this project is to transform “The Musculoskeletal Knowledge Portal (MSKKP)” from an early- stage resource into an established biomedical knowledgebase. We will engage experts in musculoskeletal research to curate and integrate musculoskeletal-specific `omics datasets that are largely absent from disease- agnostic data repositories, process the data through analytical pipelines developed by experts in genetics and genomics, and present the resulting knowledge through simple and easy to access web-based visualizations. This project addresses a critical need in the musculoskeletal community to have a single point of entry to simple summaries of musculoskeletal-specific genetic and genomic data, enabling the broader use of these data in the study of musculoskeletal diseases like osteoporosis and osteoarthritis.